The Care Ecosystem Response to COVID-19: Accelerating Research on Dementia Care that Meets the Needs of Caregivers and Persons with Dementia during COVID-19

PROJECT SUMMARY/ABSTRACT
Dementia causes substantial burdens for patients and caregivers, which have been exacerbated by the COVID-
19 pandemic. The current state of dementia care is inadequate to meet the needs of this growing, vulnerable
population. Scalable, effective, and person-centered dementia care models that are aligned with value-based
healthcare reforms are needed now. The Care Ecosystem is an accessible, remotely delivered team-based
dementia care model, designed to add value for patients, providers and payers in complex organizational and
reimbursement structures. Care is delivered via the phone and web by unlicensed Care Team Navigators, who
are trained and supervised by a team of dementia specialists with nursing, social work, and pharmacy expertise.
Care Protocols guide proactive, quality care that is documented in the electronic health record. The evidence
base to date suggests that the Care Ecosystem improves outcomes important to people with dementia,
caregivers, and payers when delivered in a controlled research environment, including reduced emergency
department visits, higher quality of life for patients and lower caregiver depression. We propose a rapid pragmatic
trial in 6 health systems serving geographically and culturally diverse populations. We will leverage technology,
delivering care via the phone and web and using electronic health records to monitor quality improvements and
evaluate outcomes while maximizing external validity. In Aim 1, we will use implementation science to identify
the model adaptations, facilitators, and barriers to implementing and sustaining the Care Ecosystem during the
COVID-19 pandemic. In Aim 2 we will use mixed methods to rigorously evaluate the effectiveness of the Care
Ecosystem on outcomes important to patients, caregivers, healthcare providers, and health systems during the
pandemic. In Aim 3, we will characterize the patient and caregiver factors associated with treatment benefit.
This will include investigating effectiveness in underrepresented groups and elucidating unmet needs that will
guide future development work. By simultaneously evaluating the real-world effectiveness and implementation
strategies in diverse health systems, this project will bridge the science-practice gap in dementia care during an
unprecedented time of heightened strain on family caregivers, healthcare providers and health systems.
Furthermore, this work will pave the way for expanding access to high quality dementia care in the future,
mitigating the negative impact of dementia on patients and their families across the nation.

Public health relevance
PROJECT NARRATIVE The COVID-19 pandemic has exacerbated the burdens of families living with dementia, whose needs are not met by traditional health care models. This project will accelerate research on the effectiveness and implementation strategies of a remotely-delivered collaborative care model for dementia, the Care Ecosystem, in 6 healthcare systems. During this unprecedented time of heightened strain on family caregivers, health care providers and health systems, will identify the effects of the Care Ecosystem on outcomes important to patients, caregivers, healthcare providers, and healthcare systems, and we will identify strategies that will facilitate successful implementation and sustainment.